Identifying the Role of Fibroblast-Macrophage Crosstalk in Aortic Valve Stenosis Sexual Dimorphism

PROJECT SUMMARY/ABSTRACT
Thirteen percent of adults over 75 suffer from aortic valve stenosis (AVS), a progressive disease that leads
to aberrant collagen deposition, leaflet stiffening, and eventual valve calcification at late stages. As it stands,
surgical or transcatheter valve replacement is the only treatment option for severe AVS and is limited in durability
and can require indefinite anticoagulation therapy. AVS is also sexually dimorphic with men having a two-fold
higher risk for developing direct calcification, whereas women with equal disease severity tend to have more
valvular fibrosis prior to calcification. The molecular mechanisms underlying sexual dimorphism in AVS
progression remain poorly understood, but growing evidence suggests AVS is an inflammation-dependent
disease. Recent studies have focused on the role that infiltrating immune cells such as macrophages play in
AVS, with a growing appreciation that men and women undergo different immune responses and show
differences in compositions of inflammatory cytokines. Combined, these observations suggest not only the need
for alternative treatments for AVS (e.g., pharmaceutical therapies), but also the opportunity to develop
personalized treatments based on sex and inflammatory state. Based on the extant evidence, we propose to
investigate the role of inflammation in sex-specific valve disease progression. We hypothesize that AVS sexual
dimorphism is perpetuated by: 1) sex differences in valve cell secreted factors promoting differential polarization
of macrophages, 2) differences in infiltration behavior of male and female macrophages, and 3) direct
macrophage-valve cell contact eliciting distinct phenotypic differentiation dependent upon sex, leading to the
formation of a pro-fibrotic or pro-calcific niche. We will test these hypotheses with the following specific aims (1)
Delineate how secreted factors from valve cells effect macrophage phenotype and vice versa in a sex-dependent
manner, (2) Elucidate sex-specific differences in AVS disease initiation within an in vitro 3D co-culture model.
The applicant, Dr. Alex Khang, will work with sponsor, Dr. Kristi S. Anseth, collaborating investigators with
expertise in immunology (Dr. Laurel Hind) and sex-specific differences (Dr. Leslie Leinwand), and microscopy
consultant Dr. Joseph Dragavon to carry out the experimental studies. All studies will be performed at the
University of Colorado Boulder. All members of the research team and the required equipment for the proposed
research are housed in the same building (Jennie Smoly Caruthers Biotechnology Building, JSCBB) which will
facilitate constant interactions as well as frequent opportunities for mentorship, while eliminating logistical issues.
The JSCBB also houses numerous faculty that are domain-experts and word-leaders in their respective field
who Dr. Khang will interact with frequently at local seminars and events. During the funding period, Dr. Khang
will gain expertise in engineering in vitro co-culture models, immunology, sex-specific differences, and advanced
light microscopy. The funding period will also enable Dr. Khang to expand his network and attend new
conferences, which will further add to his knowledge and training toward an independent research career.

Public health relevance
PROJECT NARRATIVE Aortic valve stenosis affects ~13% of the US population over 75 years of age and interestingly men have a two- fold higher risk for developing calcified valves whereas women tend to present with severely fibrotic valves. This proposal aims to investigate these sex differences, particularly the dynamic interplay between sex-specific immune cell (macrophage) interactions with resident valve interstitial cells (VICs) and how they lead to aortic valve stenosis sexual dimorphism. Our approach includes the 3D culture of VICs and macrophages in hydrogel matrices to identify the effects of secreted factors and direct contact on their phenotype and function, toward revealing targets for sex-specific, non-surgical (e.g., pharmaceutical) therapies.